Regulation of cardiac metabolism during Leukemia

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease (CVD) and cancer are the leading causes of morbidity and mortality. Leukemia is a
specific type of blood cancer and among the deadliest cancers in the United States. Patients with acute myeloid
leukemia (AML) are at an increased risk of heart failure even after disease remission. In the heart,
cardiomyocytes are critical to maintaining the pump function, and our prior work establishes that the production
of cancer-specific metabolites, or oncometabolites, impairs contractile function during leukemia. However, the
mechanisms that drive structural remodeling during disease progression and after recovery have remained
unknown. Analysis of AML has recently revealed recurrent mutations in several genes associated with metabolic
and epigenetic processes, including TET2 and IDH2. Somatic mutations of TET2 or IDH2 cause dysregulated
metabolism and clonal hematopoiesis in AML. Furthermore, both mutations have been associated with the
production and release of oncometabolites, including D-2-hydroxyglutarate, which may systemically impact
metabolism. We recently demonstrated that the oncometabolite D-2-hydroxyglutarate disrupts cardiac oxidative
metabolism and redirects Krebs cycle intermediates. Our data support a model in which somatic mutations in
clonal hematopoiesis and AML disrupt oxidative metabolism in cardiomyocytes, resulting in reduced α-
ketoglutarate (α-KG) signaling, epigenetic activation, and subsequent structural remodeling. Three independent
specific aims are designed to extend this emerging field of cardio-oncometabolism and test the hypothesis that
myeloid TET2 and IDH2 mutations create a systemic metabolic phenotype that causes and activates the
transcriptional reprogramming, culminating in cardiomyopathy and heart failure. Aim 1 will examine alterations
in oxidative metabolism in the heart in response to mutations of TET2 or IDH2-mutant AML. Aim 2 will determine
the impact of reductive carboxylation on epigenome remodeling in the heart. Aim 3 will determine sexual
dimorphism in the development of cardiomyopathy during Idh2 and Tet2 mutations in hematopoietic stem and
progenitor cells. We have established clinically relevant AML models and designed methods to study cardiac
metabolism in vivo and ex vivo to realize these aims. Together, these approaches enable us to uncover how
Tet2 and Idh2 mutations drive metabolic and structural remodeling in the heart and identify more effective ways
to treat leukemia.

Public health relevance
RELEVANCE TO PUBLIC HEALTH NARRATIVE Cardiovascular diseases and cancer are the leading causes of death in the United States and worldwide, and improved therapies are sorely needed. The proposed study aims to demonstrate that alterations in myeloid cancer cells create metabolic dependencies in the heart and contribute to the development of heart failure. Understanding these limitations at a systems level will guide therapeutic interventions to target metabolic dependencies and prevent cardiac remodeling.